The budding yeast endocytic pathway

DESCRIPTION (provided by applicant): The discovery of a conserved pathway for endocytic internalization in budding yeast, a simple organism amenable to powerful genetic, genomic, biochemical and cell biological analysis, has created unprecedented opportunities to develop a comprehensive understanding of this complex process, and to reveal underlying molecular mechanisms. Endocytosis is a key process for specifying the molecular composition of the plasma membrane, and therefore how a cell will respond to its environment. Endocytosis also provides a portal for entry of both beneficial molecules and harmful agents into cells. Despite the importance of endocytosis for cell physiology and human health, many fundamental features of the process are obscure. How sites are initiated and what mechanisms trigger the subsequent events, which invaginate the membrane and pinch off a vesicle, are not known. In this proposal, an integrated approach, combining live-cell image analysis, genetics, mathematical modeling and biochemistry is outlined. These studies promise to elucidate molecular mechanisms that underlie the endocytic process. Two aims will be investigated. (1) How endocytic sites are initiated, matured and post-translationally regulated will be determined. The yeast Eps15-like protein, Ede1, which is among the earliest to arrive at endocytic sites, and which is among the most important proteins for endocytic site initiation and progression, will be a focal point. How Ede1 is recruited to nascent endocytic sites, and how it in turn recruits other proteins to these sites, will be investigated by a combined molecular-genetic, imaging and biochemistry approach. Roles for Ede1 phosphorylation by the novel endocytic kinase Hrr25 and for Ede1 ubiquitination, will be investigated. If, and how, these regulatory inputs are influenced by endocytic cargo will also be tested. Finally, how the rhomboid protease Rbd2 regulates the transition from the early to late stages of the endocytic pathway will be investigated. (2) The roles of specific plasma membrane lipids and protein-lipid interactions during each stage of the CME pathway will be elucidated. Endocytosis involves a series of membrane shape changes. A variety of endocytic proteins associate intimately with the lipid bilayer during each stage of the process, responding to and affecting lipid composition and membrane geometry. The specific roles and protein interactions of PS, PIP2 and sphingolipids will be investigated. Purified endocytic proteins and a recently developed cell extract system that reconstitutes the actin assembly burst near the end of the endocytic pathway will now be used to reconstitute endocytic steps on microbeads and lipid bilayers, establishing biochemical systems to reveal mechanism and to complement and synergize with powerful genetic and imaging approaches. A highly productive theory collaboration will continue to facilitate data synthesis and development of novel mechano-chemical concepts, and to generate experimentally testable hypotheses.

Public health relevance
PUBLIC HEALTH RELEVANCE: Three decades of evidence directly connects perturbation of clathrin-mediated endocytosis (CME) to a broad range of pathophysiological outcomes, including atherosclerosis, disorders of the peripheral CNS, and infection by the hepatitis C virus. Endocytosis is responsible for uptake of molecules from the plasma membrane and surrounding environment, and therefore is crucial for determining how a cell will interact with its surroundings. For these reasons, mechanistic understanding of CME is crucial to understanding normal cell physiology and a variety of pathological conditions. __SpecificAimsTextDelimiter__ 2. Specific Aims Endocytosis provides a portal for entry of both beneficial molecules and harmful agents into cells, and is a key process for specifying the molecular composition of the plasma membrane, which determines how a cell will respond to its environment. Despite the importance of endocytosis for cell physiology, many fundamental features of the process, such as how sites are initiated and what mechanisms dictate the timing of the subsequent events, which invaginate the membrane and pinch off a vesicle, are obscure. Using real-time image analysis, we previously defined a complex molecular pathway for clathrin-mediated endocytosis (CME) in budding yeast. We subsequently investigated the functions of over 60 proteins in this process, and the mechanisms by which the order and timing of their recruitment to endocytic sites is achieved. Many features of this pathway are conserved widely. Therefore, principles derived from our studies in yeast are expected to be directly applicable in more complex eukaryotes. In this proposal, an integrated approach, combining live-cell image analysis, genetics, mathematical modeling and biochemistry is outlined. These studies promise to elucidate molecular mechanisms that underlie the endocytic pathway. The following aims will be investigated: a. We will investigate the mechanisms of endocytic site initiation, maturation and regulation. During the past funding period we made very substantial progress in identifying key factors involved in endocytic site initiation and progression, positioning us to make unique, important contributions to understanding of these processes. We showed that the yeast Eps15-like protein Ede1 is among the earliest to arrive at endocytic sites and is among the most important proteins for endocytic site initiation and progression. Since little is understood about how endocytic sites are initiated and matured, we will now use a combined molecular-genetic, imaging and biochemistry approach to investigate how Ede1 is recruited to nascent endocytic sites, and how it in turn recruits other proteins to these sites. Having implicated a novel protein kinase, Hrr25 and two deubiquinating enzymes in Ede1 regulation, we will now investigate the mechanisms by which post-translational modifications of Ede1 and other endocytic proteins regulate critical steps during CME. Having obtained evidence that endocytic cargo accelerate the CME pathway, we will now investigate the underlying mechanism using classical genetic approaches. Finally, having implicated the rhomboid protease Rbd2 as a novel regulator of endocytic actin assembly, we will investigate the regulatory mechanism using biochemistry, cell biology and genetics. b. We will elucidate CME roles of specific plasma membrane lipids and protein-lipid interactions. Endocytosis involves a series of membrane shape changes. A variety of endocytic proteins associate intimately with the lipid bilayer during each stage of the process, responding to and affecting lipid composition and membrane geometry. The endocytic membrane is compartmentalized into regions bound by different proteins, which have distinct interactions with the underlying lipid bilayer. We and others have made substantial progress in defining yeast endocytic membrane shape changes by electron microscopy, and in determining which proteins are associated with different regions of the endocytic invagination at each stage. We have recently worked out purifications for many of the endocytic proteins, creating opportunities to investigate their biochemical properties, and developed an extract system that supports actin assembly from microbeads and artificial lipid bilayers derivatized with the endocytic protein Las17, which is yeast WASP. Building on these advances, biochemical studies with pure proteins and protein extracts will seek to identify the mechanisms that recruit endocytic proteins in an orderly and timely manner to endocytic sites, to determine how lipids affect endocytic protein activities, and how endocytic proteins affect lipid bilayers. The specific roles and protein interactions of PS, PIP2 and sphingolipids will be investigated using genetics, biochemistry and cell biology. An ongoing and highly productive theory collaboration will continue to facilitate data synthesis and development of novel mechano-chemical concepts, and to generate experimentally testable hypotheses. A lipid-centric, rather than protein-centric focus, distinguishes our theory work from other theory studies. Our discovery of a conserved pathway for endocytic internalization in a simple organism amenable to powerful genetic, genomic, biochemical and cell biological analysis has created unprecedented opportunities to develop a comprehensive understanding of this complex process, and to reveal underlying molecular mechanisms. Our progress during the previous funding period and our long-term excellent track record for high productivity on this project position us to continue to make important advances in this field.